Interdisciplinary Training in Alcohol Research

ABSTRACT/SUMMARY
The aim of this training program is to provide graduate students with the research skills to identify
alcohol-related risk factors by investigating their expression in response to acute and chronic exposure to
alcohol at the cellular level, behaving laboratory animal, and the human subject. The training program will
emphasize training in cellular and behavioral pharmacology of alcohol with the broad objective to understand
how such acute and chronic reactions combine or interact with personal and environmental factors to confer
risk for alcohol use disorders. The training is designed to achieve three objectives: 1) deliver intensive training
in alcohol research; 2) foster interdisciplinary and translational perspectives on alcohol research; and 3)
develop professional skills to support career development in alcohol research fields. The proposal requests
support for five pre-doctoral appointments. The appointments will be for a two-year period. Training will be
primarily delivered within the research programs of the faculty and the core facilities at UK. This includes a
training faculty team of 20 researchers drawn from six academic and research units of the University of
Kentucky. The rich environment provides opportunities for translational and multidisciplinary bio-behavioral
research training in facilities such as the: 1) Center on Drug and Alcohol Research; 2) Center for Clinical and
Translational Science; and 3) The Substance-abuse Prevention in Emerging Adults Research Center
(SPEAR). The alcohol-specific expertise and broad research foci of our faculty, coupled with their
interdisciplinary research provides a solid foundation by which implementation of the proposed T32 training
program will bolster the research skills of our students for the ultimate goal of producing bright, productive
scientists capable of significant developments and discovery in the etiology, prevention, and treatment of
alcohol use disorders.

Public health relevance
The purpose of this application is to initiate a translational and interdisciplinary training program in alcohol research. This multidisciplinary program will provide training in bio-behavioral factors associated with in alcohol-use disorders at the pre-doctoral level; graduates of this program w i l l b e actively involved in research, teaching, publishing articles, and becoming independent researchers in the alcohol field. We aim to establish a program of excellence in translational or interdisciplinary research training because the need for a translational or interdisciplinary program is greater today than ever before, and the proposed training program fills a unique niche in alcohol research.